Alterations and Renovations for Microbiome Facility

COBRE Center for Microbiome Sciences: Alterations and Renovations
Project Summary. We propose to renovate and improve two existing laboratories at the Departments of
Microbiology (B324/B324A) and Anatomy & Neurobiology (A502). Lab B324/B324A will be renovated to
house the COBRE Puerto Rico Center for Microbiome Sciences (PR-CMS) Research Core Laboratory.
Lab A502 will be renovated as a Department of Anatomy & Neurobiology research laboratory for a new
hire. These renovations of approximately 1,675 sq ft of laboratory space at the School of Medicine of the
Medical Sciences Campus will be key to advance the COBRE PR-CMS aims at fostering development
of meritorious junior investigators into competitive researchers working on projects with broad biomedical
significance, and establish the only a facility in the island to directly support the development of
microbiome research projects.